Regulating Skeletal Stem Cell and Neutrophil Dynamics for Improved Cleft Palate Bone Regeneration by Newly Designed Surrogate Bone Morphogenetic Protein-2

Cleft Lip and Palate (CLP) is one of the most frequent birth anomalies, currently treated with autografts from
the iliac crest. This approach involves multiple invasive surgeries and suffers from graft failures and high donor
site complications. Currently, the only other viable treatment option is Bone Morphogenetic Protein-2 (BMP-2)
based bone regeneration, which offers a less invasive alternative by eliminating the need for autografts. Yet,
FDA approval of BMP-2 is currently limitted by two issues: variability in its bone regenerative effectiveness—
particularly, clinical meta-analyses indicate a lower efficacy in palatal bone compared to mandibular bone—and
its propensity to induce significant tissue inflammation via interaction with immune cells. Thus, there is a critical
need to solve significant knowledge gaps on (1) the mechanism behind the varied success of BMP-2 in palatal
versus mandibular bone repair and (2) the dynamics between BMP-2 and immune cells to improve the BMP-2
based palate bone repair. As BMP-2 is known to enhance bone repair by activating endogenous skeletal stem
cell (SSCs), investigating the palatal bone regeneration from SSC point of view is critical. Dr. Takematsu’s
preliminary data suggest that differences in the subpopulations and BMP receptor (BMPR) usage between
palatal and mandibular SSCs contribute to variations in bone regeneration. Thus, she will identify how BMP-2
based palatal and mandibular bone regeneration is regulated by SSCs at the cellular and receptor level (Aim1).
She will employ single-cell RNA sequencing (scRNAseq) to identify if the differences in SSC subpopulations
are responsible for the varied regenerative capacities. To understand how different BMPR utilizations by SSCs
lead to diverse regenerative results, she has engineered a surrogate BMP-2 made of a bispecific nanobody.
This innovative tool will pair the specific BMPRs, allowing the investigation of their interactions and bone
regenerative capacity of SSCs. Building on her preliminary data that indicate neutrophils (NPs) contribute to
inflammation, she will identify the interactions between NPs and SSCs in the palatal bone regenerative
interface and develop safe bone regeneration strategies using the surrogate BMP-2 (Aim2). She will examine
the genetic interplay between NPs and SSCs in palatal bone defects repaired by BMP-2 using scRNAseq and
will develop strategies to mitigate NP-induced inflammation. By leveraging the differential BMPR expression
between NPs and SSCs, she can also create the surrogate BMP-2 to selectively activate SSCs and avoid NP-
induced inflammation. This project will advance Dr. Takematsu’s career goal of becoming an investigator
specializing in craniofacial SSC biology with an emphasis on osteoimmunology, aiming to control the complex
immune interactions and improve the protein therapeutics for craniofacial bone repair. With the mentorship and
a research-enriching environment at Stanford University, she will be well-equipped for applying to an
independent faculty position. The K99/R00 research will yield robust data to support a R01 proposal, focused
on developing safe and effective bone regeneration strategies to repair various craniofacial bone defects.

Public health relevance
Project narrative Bone Morphogenic Protein-2 (BMP-2) offers a less invasive alternative to the conventional autografting treatment for cleft palate repair, yet it has not received FDA approval due to insufficient bone regenerative efficiency and significant inflammatory reaction of immune cells. As BMP-2 acts on skeletal stem cells (SSCs) to regenerate bone, research into the mechanism of bone repair from a SSC perspective will provide essential information to improve palate bone regeneration efficiency. My research also aims to elucidate the influence of neutrophils on inflammation and further develop strategies for safe and efficient BMP-2 based palate bone repair, aligning well with the mission of the NIDCR.